Melanocortin 4 receptor agonists to treat sleep disordered breathing in obesity

Obesity hypoventilation syndrome (OHS) is a severe form of sleep disordered breathing (SDB) characterized by
daytime hypercapnia and hypoventilation during sleep. OHS is driven by chronically decreased CO2 sensitivity
and depressed ventilatory responses to CO2 (hypercapnic ventilatory response, HCVR). Non-invasive
ventilation restores CO2 sensitivity and treats OHS. However, adherence to this treatment is poor. There is no
effective pharmacotherapy for OHS. Leptin increases HCVR and treats hypoventilation in leptin deficient ob/ob
mice. Diet-induced obese (DIO) mice emulate all features of human OHS, including awake hypercapnia, upper
airway obstruction during sleep and sleep hypoventilation. However human and mouse DIO become resistant to
leptin limiting leptin as a pharmacotherapy. This proposal is focused on identifying pharmacological targets
downstream of the leptin network to treat OHS. Leptin upregulates pro-opiomelanocortin, which is a pre-
hormone post-transcriptionally processed into several peptides, including α melanocyte stimulating hormone, a
ligand for the melanocortin 4 receptor (MC4R) promoting energy expenditure. The MC4R agonist setmelanotide
has been approved for treatment of genetic forms of obesity linked to mutations in the POMC/MC4R/leptin
pathways. The role of MC4R in control of breathing remains unknown. Our exciting preliminary data shows that
setmelanotide augments the HCVR and treats SDB in DIO mice, that chemogenetic activation of MC4R (+)
neurons in the parafacial region containing the chemosensitive retrotrapezoid nucleus (RTN) increases baseline
ventilation and HCVR without any effect on metabolism; and that MC4R (+) parafacial neurons project to
brainstem respiratory premotor neurons, that, in turn, project to the phrenic motor nucleus. Our overarching
hypothesis is that MC4R agonists treat OHS by augmenting hypercapnic sensitivity in MC4R+ neurons
in the parafacial region, which is a major center of CO2 sensitivity. In Specific Aim 1, we will determine
the therapeutic benefits of the MC4R agonist setmelanotide in OHS in DIO mice. We hypothesize that (A) a
single dose will acutely; and (B) a three-month course of setmelanotide will chronically augment HCVR and
abolish SDB in randomized placebo-controlled trials; and that (C) the effect of setmelanotide on ventilation will
be prevented by the MC4R blocker SHU9119. In Specific Aim 2, we will use DIO Mc4r-Cre mice to examine if
the respiratory effects of MC4R activation by setmelanotide can be mimicked by chemogenetic activation and
attenuated by chemogenetic inhibition of MC4R+ parafacial neurons. In in vitro Specific Aim 3, we will examine
the synaptic neurotransmission from MC4R (+) neurons in the parafacial region to the rostral ventral respiratory
group (rVRG) neurons that project to the phrenic motor nucleus using selective expression of ChR2 in Mc4r-Cre
parafacial neurons, retrograde identification of spinally projecting rVRG neurons and patch clamp
electrophysiology. CO2/pH chemosensitivity markers of RTN will be detected in MC4R(+) neurons projecting to
rVRG. The proposal will provide a rationale for the therapeutic development of MCR4 agonists in OHS.

Public health relevance
Obesity hypoventilation syndrome, accumulation of carbon dioxide in the body, is the most severe form of sleep disordered breathing, which does not have effective drug therapy. We have collected preliminary data showing that a melanocortin 4 receptor (MC4R) agonist setmelanotide, which is FDA approved to treat genetic obesity, is a powerful stimulator of breathing, and will perform a randomized controlled trial of this drug in mice with obesity hypoventilation and sleep apnea. We will employ state-of-the-art neuroscience tools to identify specific neurons in the brain in which MC4R agonists work to stimulate breathing, enhance responses to carbon dioxide and treat obesity hypoventilation and sleep apnea.